EFFICACY OF RECOMBINANT GAMMA INTERFERON IN PATIENTS WITH T-CELL LYMPHOMA

The study is a Phase II study to determine the efficacy of recombinant human interferon gamma in patients with cutaneous T cell lymphoma.